Targeting AML Mitochondria by Ceramide

SUMMARY
This proposal's long-term objective is to develop a mechanism-based therapeutic drug for the treatment of
human acute myeloid leukemias (AML), which are among the deadliest cancers in the United States. Despite
some advances in treatment, survival for AML has not improved significantly in decades, with rare exceptions
for specific subclasses. While targeted therapies with FLT3, IDH, and Bcl-2 inhibitors have increased response
rates significantly, survival has been extended only by several months. Thus, novel and innovative therapeutic
drugs are needed to improve the survival outcomes of AML patients. The sphingolipid ceramide, an emerging
tumor suppressor lipid, mediates anti-proliferative signaling events in response to various stress stimuli,
including tyrosine kinase inhibitors (TKIs). Our published and unpublished data suggest that decreased levels
of C18-ceramide might be critical in the pathophysiology, progression and drug-resistance of AML. These data
also revealed that reconstitution of C18-ceramide by molecular and pharmacologic tools results in the
suppression of AML growth, and help overcome drug resistance. Because of pharmacologic challenges of the
conventional exogenous short-chain ceramides, we have developed novel mitochondrial targeted pyridinium-
C18-ceramide (Pyr-Cer) analogs that induce cancer cell mitophagy and tumor suppression. These Pyr-Cer
analogs exhibit increased water solubility, cell-membrane permeability, and cancer cell-selective mitochondrial
uptake, compared to uncharged conventional ceramides. Pyr-Cer analog drugs, such as LCL461 (patented
Class I) or LCL768 (Class II), contain a positive charge at a delocalized pi-electron system. This then results in
preferential localization of the drug into highly negatively charged mitochondria in cancer cells/tissues due to
the Warburg effect. The accumulation of Pyr-Cer in mitochondria results in cancer cell death via induction of
mitophagy by reducing cellular energy generation and decreasing the synthesis of other vital macromolecules,
such as nucleotides. This effect of Pyr-Cer on mitophagy induction is further increased when cancer cells are
exposed to general ROS/RNS inducer sodium selenite that causes Drp1 activation and mitochondrial fission.
Thus, we have generated a new (Class II) Pyr-Cer analog drugs conjugated with sodium selenite, named as
SoSe-C18-Pyr-Cer (LCL768), which selectively induced mitophagy-dependent cell death in AML in situ and in
vivo. Based on these data, our goal is to develop LCL768 as an anti-cancer drug for the treatment of AML. In
these feasibility studies, we will: 1) Validate the mechanism by which Pyr-Cer drugs target AML mitochondria
by mitophagy in vitro; and 2) Determine bioactivity, toxicity, pharmacokinetics and anti-AML activity of LCL768
in vivo. We will determine the possible off-target effects, maximum tolerated dose (MTD),
pharmacokinetic/pharmacodynamic profiles and anti-AML effects of LCL768 in various models. These include
drug sensitive versus resistant AML xenografts, AML PDXs, and primary AML blasts. This Phase I feasibility
study will help the commercial development of LCL768 for a Phase II application.

Public health relevance
NARRATIVE The main objective of this proposal is to develop a mechanism-based therapeutic drug for the treatment of human acute myeloid leukemia (AML) via reconstitution of tumor suppressive C18-ceramide using Class I and Class II novel pyridinium-ceramide (Pyr-Cer) analogue drugs, such as LCL461 and LCL768, which selectively induce mitophagy-dependent cell death in AML.